Cell surface protein dynamics in neural circuit assembly

PROJECT SUMMARY/ABSTRACT
The central nervous system contains an enormous number of neurons that are interconnected to form the circuits
governing all brain functions. Neural circuits are built following a series of developmental steps such as neurite
guidance, target selection, and synapse formation. Cell surface proteins (CSPs) enable neurites to connect with
the correct synaptic partners. CSPs are not static within the membrane. They undergo dynamics and can be
cycled on and off of the membrane which influences how they respond to and control the physiological and
signaling events underlying neurodevelopment. Endocytosis internalizes CSPs from the membrane into the
cytosol and has dramatic effects on CSP signaling and function. However, CSP endocytosis has largely been
investigated in the context of a few known dynamic CSPs and mostly in culture systems. Though these
approaches are informative, we still do not know the identity and number of endocytosed CSPs within a given
developmental context or how their dynamics impact circuit assembly in vivo. The Drosophila olfactory system
displays stereotyped wiring and high genetic tractability, making it a powerful in vivo system to elucidate the role
and regulators of dynamic CSPs in circuit assembly. Here, ~57 distinct types of olfactory receptor neurons
(ORNs) project their axons from the periphery into the brain to make one-to-one synaptic connections with the
dendrites of ~57 corresponding types of projection neurons (PNs). This one-ORN-type-to-one-PN-type motif
creates ~57 distinct and invariant information relay channels called glomeruli. In fact, impairing CSP dynamics
disrupts olfactory circuit assembly, as well as the development of other sensory systems.
The proposal will provide foundational insight into how CSP dynamics govern olfactory circuit assembly and
enable the candidate to build an independent research direction to pursue in her own lab. Specifically, the K99
phase of this application focuses on: 1) employing cutting-edge quantitative proteomics to profile dynamic CSPs
in ORNs and PNs in the developing brain; and 2) performing functional analyses to determine how CSP
endocytosis impacts circuit formation. This work will be completed under the guidance of world-renowned
neuroscientist, Dr. Liqun Luo (mentor), expert cell biologist, Dr. Kang Shen (co-mentor) and in collaboration with
leaders in proximity labeling, Dr. Alice Ting, and mass-spectrometry, Dr. Steven Carr. The R00 phase of this
proposal seeks to evaluate the intracellular mechanisms that control CSP dynamics by building upon expertise
gained from the mentored phase of this proposal.
The research in the mentored and independent portions of this application is directly in line with NIDCD’s
mission to understand chemo-sensation and treat chemosensory disorders because elucidating the cellular
mechanisms controlling olfactory circuit assembly could enable us to ameliorate sensory circuit defects that arise
from disorders, injury, disease, or ageing.

Public health relevance
PROJECT NARRATIVE During development, neural circuits self-assemble to form the connectivity patterns governing all brain functions. This proposal seeks to elucidate conserved cellular strategies that underly neural circuit formation in the intact brain. Thus, this work will provide key mechanistic insight into an important neurodevelopmental process, which will be crucial for creating therapeutic strategies to regenerate circuits following ageing, disease, or injury.